Cellular and Molecular Mechanisms of Age-Related Retinal Degeneration

Vision loss from age-related eye diseases such as age-related macular degeneration,
glaucoma, or retinitis pigmentosa is a significant cause of morbidity in elderly Veterans. The
cellular, genetic, and molecular homeostatic mechanisms that maintain normal retinal function
and the pathomechanisms that compromise retinal function with age are poorly understood. Our
long-term objective is to decipher the protective mechanisms required for normal retinal function
and to identify pathomechanisms that drive chronic progressive vision loss diseases. A
mechanism that we have explored in our VA Merit Award is the role of ER and oxidative stress
in progressive vision loss diseases. In particular, we have discovered that impairment of
Activating Transcription Factor 6 (ATF6) leads to vision loss in patients. ATF6 is a transcription
factor that protects cells from ER and oxidative stress. Recently, we have discovered novel
small molecule activators of ATF6 and related ER/oxidative stress regulator genes. Our central
hypothesis is that reduction of ER and oxidative stress in the eye through administration of
these small molecules will ameliorate chronic progressive retinal diseases arising from
ER/oxidative stress. Guided by this hypothesis, we propose the following Specific Aims: 1.
Determine the anti-ER stress and anti-oxidant efficacy of novel small molecule ATF6
agonists. In a screen of >500,000 small molecule compounds, we identified several different
novel molecules that selectively activate ATF6 in cell culture with no overt toxicity. We have
obtained these compounds and will perform quantitative, dose-response pharmacologic
experiments to characterize and compare the abilities of these molecules to reduce ER stress,
to reduce oxidative stress, and to prevent stress-induced damage and cell death. These studies
will reveal if ER and oxidative stress can be prevented by small molecule ATF6 activation. 2.
Test if small molecule ATF6 agonist, AA147, prevents retinal degeneration in vivo. We
found in vivo intraocular efficacy of a lead small molecule ATF6 agonist, AA147, after intravitreal
injection. We will determine the parameters for optimal AA147 efficacy via intravitreal injection.
We will perform these studies in a GFP reporter mouse of ER/oxidative stress where GFP
intensity corresponds to ER/oxidative stress levels. These studies will reveal if a novel small
molecule ATF6 agonist, AA147, can preserve retinal function through its anti-ER/oxidative
stress properties in the mouse eye. 3: Characterize the proteostatic properties of novel
small molecule XBP1 agonists. XBP1 is a transcription factor that is closely related to ATF6
and shares many transcriptional targets. Our small molecule screen also identified novel
agonists for XBP1, and our preliminary data reveals that an XBP1 agonist can robustly remove
damaged proteins from cells. We hypothesize that XBP1 agonists will reduce ER stress,
oxidative stress, and protein misfolding. We will perform cellular and biochemical studies to
characterize the properties of these new XBP1 agonists in retinal assays. These may identify a
novel strategy to prevent ER/oxidative stress by XBP1 agonism that complements ATF6
activators. The significance of our studies is that, if successful, we will decipher the role of ER
stress regulatory genes in retinal homeostasis and in retinal degeneration. These studies will
positively impact patient care by defining new molecular pathways and small molecules that
can be further advanced into pharmacologic therapies to prevent vision loss in aging Veterans.

Public health relevance
Over one million Veterans today cannot perform basic daily activities due to vision loss. These figures are expected to increase as more Veterans from the Korean and Vietnam conflict eras develop vision loss due to age-related damage to the retina. There are few treatments to prevent retinal degeneration because the mechanisms that maintain retinal homeostasis in response to environmental stresses are poorly understood. Oxidative and endoplasmic reticulum stress underlie the development of many age-related diseases. This VA merit application investigates the role of molecular regulators of oxidative and endoplasmic reticulum stress response, Activating Transcription Factor 6 and X-box Binding Protein 1, in retinal survival and degeneration. This research may identify new treatments to prevent vision loss in aging Veterans by therapeutic ATF6 or XBP1 agonists.